Distinct roles in motor sequence learning for cortico-basal ganglia circuits

PROJECT SUMMARY
The ability to seamlessly link individual movements into smooth, efficient sequences is a fundamental aspect of
human behavior, enabling everything from speaking to playing musical instruments. This process often feels
effortless, yet it relies on complex interactions between different brain regions. When these interactions break
down, as seen in movement disorders such as Parkinson’s disease, the ability to learn and execute motor
sequences can become severely impaired. The basal ganglia (BG), a set of deep brain structures, is thought to
play a key role in this process, but its precise contribution to learning and performance of motor sequences
remains unclear. Some prominent theories suggest that the BG store and select well-learned skills, while
emerging evidence instead indicates that they act as a tutor, shaping skill learning in the cortex but becoming
unnecessary once a skill is well-learned. My project will test these competing ideas by examining how different
BG circuits support different stages of motor learning. Using high-density Neuropixel probes, I will record
activity from three key cortical regions involved in movement planning and execution—primary motor cortex
(M1), supplementary motor area (SMA), and pre-supplementary motor area (pre-SMA)—as well as their
anatomically-connected regions in the BG output nucleus, the internal segment of the globus pallidus (GPi). By
comparing neural activity during both early learning and well-practiced sequence execution, I will determine
how these circuits encode motor sequences over the course of learning at the level of both single-units and
neural populations (Aim 1). To test whether these circuits are necessary for learning and recall, I will use
pharmacological inactivation with the GABA-A agonist muscimol followed by permanent lesions to disrupt GPi
output at different learning stages (Aim 2). This approach will reveal whether the BG is required for learning
and performing new sequences but not for executing highly practiced ones, providing insight into how BG
circuits interact to shape motor skill acquisition. This fellowship will provide rigorous technical training in multi-
area electrophysiology, pharmacological inactivation, and computational analysis of population-level neural
data. I will conduct this work within the Systems Neuroscience Institute at the University of Pittsburgh, which
offers a uniquely collaborative environment with extensive expertise in nonhuman primate neuroscience.
Professional development in mentorship, scientific communication, and leadership will complement my
technical training. Together, this research and training plan will prepare me to lead an independent research
program focused on the neural basis of skilled behavior.

Public health relevance
PROJECT NARRATIVE These experiments will elucidate how anatomically distinct cortico-basal ganglia circuits contribute to motor sequence learning, retention, and recall. Disruptions in these processes underlie neurological disorders such as obsessive-compulsive disorder, Tourette’s syndrome, and Parkinson’s disease. Understanding these circuits will provide new avenues for treating and characterizing deficits in sequential behavior in disease states.